Utilizing Polygenic Risk to Understand and Improve Outcomes: A Model For Overturning Health Disparities Through Minority-Enriched Genomics Healthcare

ABSTRACT
This program is focused on validating and implementing polygenic risk scores (PRS) to 750 participants at the
Children’s Hospital of Philadelphia. Under the parent eMERGE program, CHOP established an efficient
enrollment, engagement, and retention protocol that includes targeted recruitment, enhanced communication
with participants and healthcare professionals, boosted analysis and EMR integration, and a dynamic
education program focusing on AAs in order to achieve long-term success and improved health outcomes. The
program is already returning risk reports to the EMR, exploring relevant ethical, legal, and social implications
(ELSI), and investigating a range of important outcomes post-return-of-results. CHOP is on target to meet all
its major milestones, with the requisite programmatic infrastructure fully operational. Building on these
successes, we propose a range of sub-projects to supplement the existing scientific agenda.
1. Recruit and engage 750 additional participants (>75% minority/underserved): To date, 74% of the 847
participants recruited to CHOP are from minority/underserved populations, primarily AAs. We aim to expand
the program across additional clinics, all of which would be managed under the existing infrastructure. We will
return genomic risk estimates to all 750 additional participants and assess healthcare outcomes across key
disease areas and collect relevant data and assess outcomes for both patients and providers.
2. Examine ethical, legal, and social implications (ELSI) of return of genomic risk estimates: Qualitative
interviews will explore reactions to receiving a risk report incorporating polygenic risk scores among both
parents of pediatric participants and participants over 18 years of age. Primary outcomes will be the
identification of themes related to the perception of 1) self-esteem and body image; 2) stigma; and 3) behavior
change, and barriers, corresponding to recommendations for the management of disease risk.
3. Assess actions and interactions between pediatric primary care providers (PCP) and parents of pediatric
patients who received a high-risk GIRA: Through semi-structured interviews of PCPs, we will be empowered to
assess the effectiveness of the GIRA return and CDS in supporting the provider in clinical practice including
communication with parents/caregivers. This will provide a detailed analysis of the impact of EMR-based
interventions on patients and providers in the pediatric context, supplementing existing Network-wide efforts to
capture quantitative outcomes with novel qualitative data.

Public health relevance
PROJECT NARRATIVE Polygenic risk scores (PRS) use genetic data to predict the likelihood that a person will develop a specific disease/trait. Supplementing our initial target of 2500 research participants, we aim to recruit 750 additional patients, about 75% of whom will be from under-represented/minority populations, and all of whom will receive a risk report incorporating PRS. Two interview studies – one with participants, and one with health care providers – will respectively assess 1) adherence to health recommendations and psychosocial outcomes and 2) interactions between pediatric primary care providers (PCP) and parents of pediatric patients and clinical decision supports needed.